PRO-Core

ABSTRACT: PATIENT REPORTED OUTCOMES-CORE SHARED RESOURCE
The Patient Reported Outcomes-Core Shared Resource (PRO-core) was developed in response to a growing
number of cancer center investigators who require methodological consulting related to survey development,
use, and analysis, as well as use of a customizable electronic data capture tool for collecting information
directly from patients and other stakeholders. PRO Core provides a software platform and scientific
consultation to investigators conducting PRO research. This includes clinical trials of new drugs, interventions
with symptom and quality of life endpoints, and studies of the integration of PRO assessment into clinical care.
Dr. Bennett is the faculty director and an Associate Professor of Health Policy and Management. She
contributed as an investigator to the development and validation of the NCI Patient-Reported Outcomes
version of the Common Terminology Criteria for Adverse Events (PRO-CTCAE). In fiscal year 2019, the SR
was used by 27 faculty, 67% of whom were LCCC members. Importantly, the SR supports highly sophisticated
methodology and is a national leader in Patient Reported Outcomes. These skills and methods allow the SR to
support external cancer collaborators at multi-site trial locations such as Duke Cancer Institute, Emory
University, Georgetown, and Moffit. PRO is requesting $111,249 for this SR which is approximately 39% of its
fiscal year 2020 Operating budget.
PRO Core has been a successful SR as demonstrated by the following metrics. PRO Core studies are
supported by 11 NIH grants (5 from NCI, including 1 K award) and 3 Patient-Centered Outcomes Research
Institute (PCORI) contracts. Studies are also supported by Genentech, the Breast Cancer Research
Foundation, and pilot awards from the Alliance for Clinical Trials in Oncology cooperative group. PRO Core is
supporting a growing portfolio of: 1) studies evaluating the implementation of PRO assessment in oncology
care, and 2) studies collecting both PRO data and wearable / activity tracker (e.g. Garmin, Fitbit) data. PRO
Core has developed technical capability and expertise in these areas, and the LCCC is now known for
substantial scientific leadership in these two areas. In addition, PRO Core is supporting studies that evaluate
the comparative effectiveness of new treatments and a new registry that tracks opioid need and use among
post-operative patients.